Prefrontal Cortical Circuits in Aging and Frontotemporal Dementia

Project Summary
Frontotemporal dementia (FTD) is a leading cause of presenile dementia and is characterized by progressive
atrophy of the frontal and/or temporal lobes. There is no cure nor FDA-approved treatment to slow disease
progression. The most prevalent cause is a G4C2 repeat expansion located in the non-coding region of C9orf72,
leading to several pathologies including the formation of dipeptide repeat proteins. Arginine-containing
dipeptide repeat proteins, including poly(GR), are especially toxic. The most common form of FTD is
behavioral variant FTD (bvFTD), where marked changes in personality occur, including the loss of empathy,
considered one of the most distressing symptoms. Treatments aimed at alleviating the loss of empathy are
limited and the neural mechanisms underlying loss of empathy are poorly understood. Therefore, there is a
critical need to identify and develop therapeutic treatments to restore loss of empathy in bvFTD. The overall
goal is to elucidate the neural mechanisms underlying this loss of empathy and to identify potential therapeutic
targets to restore empathy in bvFTD. The dorsomedial prefrontal cortex (dmPFC) is a main site of FTD
pathogenesis and regulates empathy-driven consolation. We use a poly(GR) mouse model for bvFTD, where
poly(GR) accumulates in an age-dependent manner. Strikingly, mutant mice exhibit a complete loss of
consolation starting at 9-months of age, coinciding with middle-age. In mutant mice, we found that dmPFC
layer 5 pyramidal neurons become hypoexcitable during a transition into middle-age and that oxytocin can
restore empathy. In the F99 phase, I will establish oxytocin as a novel therapeutic strategy for the treatment of
lost empathy in bvFTD and delineate the detailed neural mechanisms and circuitry by which oxytocin restores
consolation using behavior, slice electrophysiology, and opto- and chemogenetic circuit manipulations to
establish that oxytocin in the dmPFC enables consolation and restores neurophysiology. I will learn advanced
patch-clamp electrophysiology skills and optogenetics before the transition to the K00 phase. The nervous
system undergoes numerous changes during aging. However, little is known about how the electrical
properties and associated molecular signatures of neurons change across the lifespan and in disease. There is a
crucial need to understand how alternations in these functions are disrupted in and contribute to disease. The
goal of the K00 phase is to identify age-dependent mechanisms contributing to lost empathy in bvFTD. I will
characterize age-dependent neuronal firing patterns and associated molecular signatures in wild-type and
bvFTD mice engaged in empathy behaviors and will restore impaired empathetic behavior by targeting
identified neurophysiological and molecular alternations. I will learn and use in vivo electrophysiology, single-
cell RNA-seq, and patch-seq. Completion of the F99 and K00 aims will fill critical gaps in our understanding of
the neural mechanisms of normal aging, dementia pathogenesis, and novel therapeutical development and will
provide training for me to become an academic investigator studying aging and age-related dementia.

Public health relevance
Project Narrative Behavioral variant frontotemporal dementia (bvFTD) is a leading cause of presenile dementia and is an incurable neurodegenerative disease where loss of empathy occurs; the underlying neural mechanisms underlying are essentially unknown. This study will explore oxytocin signaling enhancement as a novel therapeutic treatment for the loss of empathy and will elucidate how neuronal activity and associated molecular signatures within empathy circuits change across the lifespan during healthy aging and bvFTD, with the overall goal to provide novel therapeutic targets to improve quality of life. Successful completion of this fellowship application will generate important insights into bvFTD pathogenesis and therapy and provide valuable training necessary to launch my career as an academic scientist.